BIOMEDICAL COMPUTING SUPPORT SERVICES

Provide biomedical computing support services to the Biostatistics Branch, Division of Cancer Etiology, NCI. Specifically, provide computer programming for data management and statistical analysis applications, computer systems analysis, technical documentation, operation of the Landow Building Remote terminal facility, and clerical support related to computer applications.